Biophysical modeling of the functional MRI signal through parametric variations in neuronal activation and blood vessel anatomy using realistic synthetic microvascular networks

The most widespread tool for measuring brain activity noninvasively in humans is functional magnetic resonance
imaging (fMRI), which typically tracks changes in blood flow and oxygenation using the blood-oxygenation-level-
dependent (BOLD) signal. Although BOLD is an indirect measure of neural firing, it has been shown to be a
faithful measure of brain activation, yet the details of brain vascular anatomy and physiology are known to
influence all fMRI signals including BOLD. Recently, invasive optical imaging studies in animals demonstrated
that the changes in blood flow regulation occurring alongside neuronal activity are far more precise than
previously believed, indicating fMRI can be a faithful representation of neuronal activity at fine spatial and
temporal scales. Recent biophysical simulations have further demonstrated how the microvascular network, and
the vascular response to neural activity, can influence fMRI signals in humans, suggesting that modeling can
help improve fMRI interpretation. We propose to extend this work through a series of biophysical simulations in
which we will parametrically vary vascular anatomy, neuronal activity, and the vascular response to neuronal
activity then simulate the resulting BOLD responses to characterize these influences on fMRI. We hypothesize
that the specifics of the vascular anatomy and neuronal activity patterns will both have measurable effects on
the fMRI signal and that our modeling framework can predict these influences—which can improve inferences
of neural activity from fMRI. This approach is only now possible due to the availability of sufficiently-large-scale
microscopy data, our highly efficient computational framework, and our novel vascular synthesis algorithm.
For this work we will extend our new blood flow and oxygen transport framework to simulate vasomotive
responses to neuronal activity, then incorporate MR physics to generate the corresponding BOLD signals. Our
modeling platform provides unique capabilities: synthesis of realistic, large-scale vascular networks with fully
controllable geometry, density, and topology; and robust simulations of vascular systems far larger than ever
attempted. This will allow for accurate, efficient calculations at a sufficient scale to generate meaningful BOLD
responses that can be related to human fMRI data. We will test whether other aspects of the hemodynamic
response may provide more faithful representations of neuronal activity. Finally, we will test our model predictions
against empirical data with a simple, high-resolution human fMRI experiment. This work spans four Aims. In Aim
1 we compare four candidate “scenarios” describing the vascular response to neural activity. In Aim 2 we test
the dependence BOLD on vascular anatomy by synthesizing large-scale vascular networks. In Aim 3 we test
dependence of patterns of neuronal activity on BOLD by simulating systematically varying spatiotemporal
patterns of neuronal activity. In Aim 4 we test model predictions through a high-resolution human fMRI
experiment measuring BOLD responses to parametrically varied neuronal activity patterns. The outcome of this
work will be a characterization of fMRI signal dependence on factors that cannot be measured in humans in vivo.

Public health relevance
PROJECT NARRATIVE Functional Magnetic Resonance Imaging (fMRI)—the most common technique for mapping brain function in humans—is based on tracking local changes in blood flow and blood oxygenation that occur during brain activity, and therefore is only an indirect measure of neuronal firing, however recent studies have shown that the fine controls of blood delivery in the brain are much more precise than what was previously believed. Nevertheless, the fMRI signals are strongly influenced by the spatial patterns of blood vessel anatomy and the temporal patterns of the blood vessel response to brain activity as well as by the underlying patterns of neuronal activity, and previous work has shown that even these microscopic details can impact modern fMRI measurements made in human volunteers. In this BRAIN Initiative postdoctoral fellowship, we will develop a computational framework to faithfully simulate the fMRI signals—with realistic patterns of neuronal activity and the vascular response—to better understand how to relate fMRI measurements to the underlying neuronal activity.